Peer Recovery Coaching for Promoting Tobacco Abstinence in People with Opioid Use Disorder

ABSTRACT/PROJECT SUMMARY
Tobacco use is a leading cause of premature death among individuals with opioid use disorder (OUD). Nearly
75% of individuals receiving medication treatment for OUD report concurrent tobacco use disorder (MOUD-
TUD), yet evidence-based TUD treatment (i.e., FDA-approved medications and counseling) is less effective in
those with MOUD-TUD compared to the general smoking population. Innovative interventions for promoting
TUD cessation in individuals with MOUD-TUD are urgently needed. Major factors maintaining TUD in those
with OUD that have not been addressed in existing treatment interventions in this population are the small
social networks comprised of other smokers, pro-smoking social norms in social networks, and limited social
support for quitting smoking. Peer recovery coaches (PRCs) are people with lived OUD experience who
provide peer coaching to individuals with OUD and have been shown to promote increased OUD treatment
retention and illicit opioid abstinence. PRCs who are in OUD-TUD recovery and trained in TUD treatment, are
well positioned to provide a social model for nonsmoking and to alter the pro-smoking social norms that
maintain TUD in those receiving MOUD; but this has never been tested. We hypothesize that a tobacco
cessation intervention, delivered by PRCs in OUD and TUD recovery with TUD training, combined with a safe
and effective FDA-approved cessation medication (dual NRT), will be feasible, acceptable and have a greater
effect on tobacco abstinence rates than current standard care TUD treatment (non-peer delivered TUD
coaching plus dual NRT). To test this hypothesis, in this 3-year pilot R34, we propose to adapt a behavioral
TUD intervention, PeerTTS, to people with OUD and TUD and to train PRCs in OUD and TUD recovery to
deliver the intervention. We will then conduct a pilot RCT in 60 participants with MOUD-TUD interested in
reducing or quitting tobacco at MGH. Participants will be randomized to receive 12 weeks of 1) PeerTTS,
defined as PRC-delivered tobacco cessation coaching plus dual NRT or 2) standard care (SOC), defined as
non-peer delivered TUD coaching plus dual NRT. The proposed work will adapt and test whether a peer
recovery coach-delivered tobacco cessation intervention is feasible, acceptable, and potentially more effective
than standard care, when combined with first line pharmacotherapy in those with MOUD-TUD. The pilot RCT
will provide quantitative and qualitative data to inform a fully powered R01 or equivalent (e.g., NIDA PAR-22-
182) testing a refined version of the PeerTTS intervention for individuals with MOUD-TUD who face a
disproportionate burden of tobacco use and related mortality. This proposal aligns with NIDA’s high priority
research areas to test novel treatments that sustain recovery in individuals with poly-SUD (OUD and TUD)
and to advance the science of peer recovery support. It also aligns with calls from the USDHHS to enhance
PRC training to include additional evidence-based competencies that improve health.

Public health relevance
PROJECT NARRATIVE Tobacco use is a leading cause of preventable death among individuals receiving medication treatment for opioid use disorder (MOUD). Existing evidence-based tobacco treatments are suboptimal for individuals receiving MOUD and no studies have addressed the social factors that contribute to continued smoking in this population (e.g., small social networks enriched with smoking peers, limited social support for quitting). This project will adapt and test the PeerTTS intervention, a novel peer recovery coach-delivered (delivered by peer coaches in OUD and TUD recovery) behavioral smoking cessation intervention paired with dual nicotine replacement therapy (NRT) compared to standard care tobacco treatment (non peer-delivered counseling and dual NRT), for individuals receiving MOUD and interested in quitting smoking, to inform tobacco control efforts and calls from the USDHHS to expand the training of peer recovery coaches.